Optimization of a Novel Thread Geometry for Various Orthopedic Surgery Applications

PROJECT SUMMARY/ABSTRACT
The majority of threaded interfaces (screws) used in orthopaedics utilize a buttress thread design which has
limitations in clinical application. Clinically, orthopaedic screws must resist the dynamic forces generated during
common activities of daily living, yet buttress screws are not designed to resist multidirectional force, leading to
increased risk of postoperative complications including screw loosening and failure of fixation. Since the
modifiable variables of buttress screw designs—including thread pitch, depth, width and face angle—are
interrelated, attempts to improve screw functionality by altering these variables is limited. The challenge in bone
threaded surface interface is in the optimization of threaded surfaces that meet the loading scenarios at different
anatomic sites with varying bone stock, more often than not, one of poor bone quality.
The development of innovative bone-screw-fastener technologies for the field of orthopaedic surgery is the
underlying focus of OsteoCentric, Inc., a small business based in Austin, TX. The company has designed,
manufactured and implemented a new bone-screw-fastener design, the Bone Interlocking Thread Geometry
(BITG), based on a technology that creates a circumferential interlocking interface that maximizes bone volume
and preserves bone architecture. The BITG overcomes many of the limitations of buttress screws by resisting
multidirectional forces and bending moments, minimizing radial forces, and allowing for higher finishing torques.
These enhancements can prevent fixation construct failure especially with cases with inadequate bone quality.
We have successfully developed and validated bone-thread-interface Finite Element (FE) models for three
loading conditions and have conducted a parametric FE analysis to optimize the BITG thread pitch geometry.
The SBIR Phase II proposal seeks to build on our early success by optimizing the thread geometry; testing it in
a large animal model; and optimizing the BITG thread manufacturing methodology. This will enable OsteoCentric
to market a clinically superior product that reduces the overall cost of implants to the healthcare system by
utilizing more cost-effective non-locking screws and plates. The specific aims of the Phase II are: Specific Aim
1: Conduct a comprehensive parametric analysis of the BITG using validated FE analysis to optimize cortical
and cancellous thread geometry for normal and osteoporotic bones. Specific Aim 2: Optimize methods of BITG
manufacturing to enhance cost-effectiveness and efficiency; build internal prototyping and manufacturing
expertise; and build an education package for outsource production manufacturers to streamline BITG
technology production. Specific Aim 3: Test the optimized BITG thread design against traditional buttress screw
using an ovine fracture model in both normal and osteoporotic conditions.

Public health relevance
PROJECT NARRATIVE The threaded screws used in orthopaedic surgery share a common buttress design that has intrinsic weaknesses, potentially increasing the risk of postoperative complications. OsteoCentric has developed a novel thread-interface technology designated Bone Interlocking Thread Geometry (BITG) which seeks to mitigate these weaknesses. We have sought to optimize BITG after validating a bone-thread-interface Finite Element model. This SBIR Phase II proposal will continue with design optimization, followed by a large animal model study and optimization of the manufacturing methodology for the new thread geometry.